Biomedical Informatics and Data Science at Institute for Informatics (BIDS@I2)

Project Summary
Biomedical Informatics and Data Science at Institute for Informatics (BIDS@I2) provides opportunities for
undergraduate and masters’ students to explore the field of biomedical informatics and data science; to train
future biomedical researchers in biomedical informatics and data science core competencies; to engage
students in scholarly activities under the guidance of experienced informatics and data science faculty; and
lastly, to foster their understanding of translating biomedical informatics research into practice. The objectives
of the BIDS@I2 are to 1) expand students’ knowledge of theories and applications in biomedical informatics; 2)
provide training and hands-on research experience in biomedical informatics and data science research; 3)
assist students in enhancing and applying their knowledge and skills in translational science and dissemination
of research findings; 4) encourage students to pursue graduate education and/or research careers through
exposure to professional role models or mentors; and 5) develop and improve students’ skills in
interdisciplinary teamwork and communication. BIDS@I2 offers an unique environment for undergraduate and
graduate students to explore the diversity within biomedical informatics research.
BIDS@I2 has the capacity to host approximately 20 students each year. We request funding from the NLM
R25 Research Education Program to support 5 undergraduate and 4 masters students each year to cultivate a
BIDS career pathway. We will allocate at least 67% of the R25 fund to URMs (4 undergraduate URM and 2
master URM trainees), which will comprise roughly 30% of BIDS@I2 students each year. In addition, we will
recruit at least 50% of students from schools with limited resources for research. Students’ research
experiences will be enhanced through our structured training curriculum: orientation, training modules, lunch
and learn research seminars, mentor lab meetings, scientific presentations, and writing, as well as through
interactions and collaborations with peers, fellows, and graduate trainees from multiple disciplines, such as
medicine, nursing, pharmacy, psychology, public health, biostatistics, and computer science.
BIDS@I2 will promote interdisciplinary collaboration in biomedical informatics, which aims to solve problems in
clinical practice, individual and population health, data science, and biomedical research through the optimal
use of information. BIDS@I2 will support the following areas: 1) an inclusive and supportive environment for
students with limited resources and from underrepresented groups; 2) diverse research directions to
accommodate students with various backgrounds and skills; 3) interdisciplinary collaboration across the
spectrum of biomedical informatics and data science; 4) research projects with a long-term impact on the use
of information to improve clinical practice, life science, and patient-centered outcomes; and 5) prepare students
for graduate school as well as future careers in STEM research.

Public health relevance
Project Narrative Biomedical Informatics and Data Science at Institute for Informatics (BIDS@I2) is a summer internship program aiming to provide opportunities for undergraduate and master students to explore the field of biomedical informatics and data science. BIDS@I2 will support the following areas: 1) an inclusive and supportive environment for all students, with special efforts to recruit students with limited resources and from underrepresented groups; 2) diverse research directions to accommodate students with various backgrounds and skills; 3) interdisciplinary collaboration across the spectrum of biomedical informatics and data science; 4) research projects with a long-term impact on the use of information to improve clinical practice, life science, and patient-centered outcomes; and 5) prepare students for graduate school as well as future careers in STEM research.